Cellular Approaches to Tissue Engineering and Regeneration

The University of Pittsburgh seeks continued support for multidisciplinary and innovative pre-doctoral training in
Regenerative Medicine via the Cellular Approaches to Tissue Engineering & Regeneration (CATER) training program.
The CATER program combines faculty and research expertise from an eclectic group of disciplines that combine tissue
engineering with molecular and cellular approaches of therapies for human disease and regeneration. Regenerative
medicine is truly a multidisciplinary field that brings together scientists from human biology, engineering, medical
devices, material sciences, development, pathology, systems biology and applied technologies to focus on the repair and
replacement of human tissues to restore form and function. A significant challenge in regenerative medicine is
developing the next generation of experts with intellectual grasp of these diverse disciplines. This was the impetus
behind the inception of the CATER program, which enabled cross-disciplinary training transcending the more traditional
departmentally-focused research training programs. The CATER pre-doctoral training program embraces this
multidisciplinary collaborative sentiment for research and education in regenerative medicine, abolishing silos within
disciplines and remains the hallmark of the CATER program. The students matriculate into CATER program from the
Bioengineering Graduate program in the School of Engineering or Interdisciplinary Biomedical Graduate program
from the School of Medicine usually in their 2nd year based on successful nomination and evaluation for academic
excellence and research in regenerative medicine. While CATER trainees are funded for the next 2 years as they
accomplish coursework, develop research projects and become part of a robust, interactive and collaborative community,
they remain part of CATER activities until their thesis defense and beyond. The goal of the CATER training program is to
provide a solid foundation upon which to build a productive and independent career in regenerative medicine for human
disease and injury. This goal is accomplished via a highly coordinated and mentored interdisciplinary training program,
which combines required and elective courses, research and specialized training opportunities, including internships and
professional development activities. Having been funded for 15 years, the CATER program continues to provide what
we believe is timely, innovative and outstanding training in all key areas critical for success in regenerative medicine.
CATER trainees have successfully established research programs in academia or industry, joined industry or government
in regulatory domain, and have even gone on to more diverse professions like intellectual property law and FBI. We
are confident that our program will continue to ‘cater’ to the evolving needs of our trainees and toward the advancing
definition and depth of regenerative medicine as a discipline. We request continued support of NIBIB for 6 training slots
to continue training our next generation of scientists practicing regenerative medicine, through coordinated,
interdisciplinary and rigorous didactics; research; and professional training, via the CATER program.

Public health relevance
The University of Pittsburgh pre-doctoral training program in Cellular Approaches to Tissue Engineering and Regeneration educates and trains the next generation of scientists in regenerative medicine. Our multidisciplinary training creates researchers who can provide new therapies for all eligible diseases through regenerative medicine.